COLLABOR PROG/PSYCHOBIOLOGY OF DEPRESSION/CLIN STU

The Clinical Studies of the NIMH Collaborative Program on the Psychobiology of depression involves an interrelated and coordinated group of investigations conducted on two samples drawn from five center -- mood disordered probands and their relatives. This application seeks to continue the follow up of the samples and to implement several new, but related aims: 1) investigation of the long-term course of illness in probands, relatives, spouses and controls; 2) determination of predictors of onset and recurrence in the same samples; 3) investigation of suicidal behavior, mortality and medical morbidity; 4) investigation of personality disorders in the samples, including validity, joint familial transmission with mood disorders, and influence on clinical course of mood disorders; 5) a genetic linkage study of unipolar and bipolar families; 6) investigation of stability of diagnosis on familial modes of transmission; 7) further investigation of secular trends in the occurrence of mood disorders. These aims have important public health, clinical and research implications.